Intrinsic and Extrinsic factors regulating neurogenic competence in hypothalamic tanycytes

Hypothalamic tanycytes have limited postnatal neurogenic competence, but the extrinsic and intrinsic
factors that promote this are not well understood. My predoctoral research identified a defined developmental
window during which neurogenic competence is lost from hypothalamic tanycytes. I have also identified the
neurogenic bHLH transcription factor Ascl1 as a candidate activator of neurogenic competence in tanycytes
and identified Shh signaling as potentially promoting the survival of tanycyte-derived neurons. In the F99 phase
of this award, I will investigate whether AAV-mediated overexpression of Ascl1 induces neurogenic
competence and whether Shh signaling promotes the survival of tanycyte-derived neurons using cell-specific
conditional genetic approaches. During the K00 phase, I will pursue postdoctoral training using zebrafish as a
model to identify gene regulatory networks controlling injury-induced hypothalamic neural regeneration,
identifying yet uncharacterized extrinsic and intrinsic mechanisms that regulate neurogenic competence in
tanycyte-like radial glial cells. By comparing these findings to data obtained from mammalian tanycytes, I plan
to identify both positive and negative regulators of neurogenic competence that could be manipulated to induce
the tanycyte-derived generation of specific hypothalamic neuronal cell types for treatment of metabolic and
other homeostatic disorders. These opportunities will advance my career as a neuroscientist and prepare me
for a principal investigator role at an R1 institution studying tanycyte biology and hypothalamic regeneration.

Public health relevance
Hypothalamic tanycytes are radial glial cells that closely resemble neural progenitors in morphology and gene expression profile, as well as retain a limited ability to generate neurons postnatally but are undetectable in adult animals. Identifying intrinsic (Ascl1) and extrinsic (Shh signaling) factors that stimulate neurogenic competence in tanycyte and differentiation of tanycyte-derived neurons that modulate body weight, could potentially be a useful means of treating obesity and metabolic disorders such as type II diabetes. In the K00 phase, I will pursue postdoctoral training to understand injury-induced neurogenic competence in Danio reiro (zebrafish) tanycytes, and gene regulatory networks controlling the regeneration of the zebrafish hypothalamus.